AcetaSTAT Validation and Commercialization

James, Laura P
Project Summary/Abstract
Acetaminophen (APAP) is the most common drug used for the treatment of pain and fever around
the world. It is also the most common cause of life threatening drug-induced liver damage.
Unfortunately, physicians have no specific test available to them to confirm the diagnosis of APAP
liver injury. Currently, physicians rely on patient history and non-specific tests of liver injury when
evaluating patients with liver injury due to APAP. Acetaminophen Toxicity Diagnostics, LLC has
developed a rapid lateral flow immunoassay that can detect APAP liver injury. Our test, known as
AcetaSTAT, is fast, easy and specific to APAP liver injury. Our plans for this commercialization
readiness program proposal include optimizing AcetaSTAT in a collaboration with DCN
Diagnostics. Secondly, we will produce AcetaSTAT according to current Good Manufacturing
Practice (cGMP). Finally, we will complete in vitro validation studies and perform a multi-site
clinical trial to examine the clinical performance of AcetaSTAT. These efforts will support the
submission of a de novo application to the Food and Drug Administration for clearance for sales
of AcetaSTAT in the US. Ultimately, AcetaSTAT will expedite and simplify the diagnosis of APAP
liver injury, prompting more rapid treatment, and saving lives.
OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page 1

Public health relevance
James, Laura P Project Narrative Acetaminophen (APAP), is commonly used around the world to treat pain and fever. APAP also causes livery injury which can be deadly. Liver injury from APAP can be challenging for physicians to diagnose because currently available tests are time-limited or not specific. We have developed a new test that will diagnosis APAP liver injury within minutes from a blood sample. We will complete the final development of our test, AcetaSTAT, and then produce it for further testing in the laboratory and in a clinical research centers who evaluate liver injury patients. We anticipate that AcetaSTAT will be positive in patients with APAP liver injury, while control subjects or patients who received non-toxic (or low) doses of APAP will have negative AcetaSTAT tests. The data from this research will be submitted to the Food and Drug Administration for its review and approval for AcetaSTAT to be sold in the United States. Once available to physicians, patients with APAP liver injury will be diagnosed more quickly and receive treatment, preventing other medical complications and death. OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page 1